Exploring how cells generate and release distinct subpopulations of dense-core vesicles

Project summary
When examined by electron microscopy, neurons can be seen to carry organelles that look like little black dots.
These black dots are called dense-core vesicles and they carry many important transmitters that act as
neuromodulators, including neuropeptides, nerve growth factors, and monoamines such as dopamine and
norepinephrine. Such dense-core vesicle cargos regulate a wide array of behaviors, and defects in such
cargos can contribute to numerous mood disorders and other neurological conditions. However, little is
understood about the cell biology of how dense-core vesicles are made, acquire cargos and mature, are
trafficked to release sites, and ultimately released. Thus, the little black dots in neurons are really a big black
box. Adding to the mysteries and complexity of these organelles, many neurons carry multiple dense-core
vesicle cargos in the same cell. Are these different cargos copackaged together in the same dense-core
vesicles or are they packaged separately in distinct vesicles? The answer to this question is surprisingly known
in only a few cases, and the general pattern of copackaging versus segregation of distinct cargos is unclear,
but is of key physiological relevance as it determines whether different dense-core vesicle cargos are
coreleased or can be released independently. Additionally, in cases where distinct dense-core vesicle
subpopulations are known to exist in the same cell, it is unclear how these distinct populations are generated
and how cargos are differentially sorted. To begin to address these gaps in understanding, here we aim to
establish two model systems for the study of distinct dense-core vesicle populations in the same cell: the ASI
sensory neuron in the nematode C. elegans and the rat pancreatic beta-cell line 832/13. Our preliminary data
show that members of a known dense-core vesicle biogenesis and maturation pathway, the Rab2/EARP
pathway, are required for one subpopulation of dense-core vesicles in both the ASI neuron and the 832/13 cell
line, but not for another subpopulation in the same cell. In Aim 1, we will further define the requirements for
members of the Rab2/EARP pathway in the biogenesis and maturation of distinct dense-core vesicle
subpopulations in the ASI neuron and 832/13 cells. Additionally, we will perform candidate screens in an
attempt to identify factors required for the Rab2/EARP-independent generation of dense-core vesicles in both
cell types. In Aim 2, we will test the hypothesis that different subpopulations of dense-core vesicles are marked
by different isoforms of the synaptotagmin family of calcium sensors. We will also determine whether these
synaptotagmins control the release of distinct dense-core vesicle subpopulations. In summary, this project will
identify the basic molecules required for the generation and release of distinct subpopulations of dense-core
vesicles in the same cell, and set the stage for more mechanistic investigations into how these processes
occur.

Public health relevance
Project Narrative Nerve cells control behavior and metabolism through the release of signaling molecules that are packaged in specialized compartments called dense-core vesicles, and abnormalities in the release of these molecules contributes to a wide range of mental disorders. It is common for individual neurons to carry multiple types of these signaling molecules, but it is generally not known whether they are stored and released together or separately in different dense-core vesicles. This exploratory study will begin to dissect the mechanisms by which neurons generate multiple types of dense-core vesicles, which should provide insights into the roles of these signaling molecules in normal physiology and disease.